Understanding the role of SCN8A in developmental and epileptic encephalopathy

PROJECT SUMMARY
Developmental and epileptic encephalopathies (DEEs) are severe early-onset seizure disorders with
treatment-resistant seizures, developmental delay/regression, and long-term cognitive and motor impairment.
SCN8A DEE, caused by gain-of-function, missense variants in the voltage-gated sodium channel gene SCN8A
(Nav1.6), is characterized by infantile-onset seizures, mild to severe intellectual disability, significant
developmental delay, and elevated risk of premature lethality. A serious comorbidity in SCN8A DEE is the
prominent motor impairment, including severe hypotonia, movement disorders, and a large proportion of
individuals that are non-ambulatory. Two mouse models carrying the patient mutations p.Asn1768Asp
(N1768D) or p.Arg1872Trp (R1872W) recapitulated seizures and early death but did not exhibit motor
impairment. Thus, insight into the mechanisms underlying motor impairment in SCN8A DEE has not previously
been possible. We developed a novel conditional mouse model of SCN8A DEE with the patient mutation
p.Thr767Ile (T767I). The T767I mouse is the first model of SCN8A DEE that exhibits significant muscle
weakness and motor impairment. Our preliminary data suggests that functional motor units are reduced in
Scn8a-T767I/+ mice. We hypothesize that the Scn8a-T767I mutation alters spinal motor neuron activity,
leading to dysfunction of the motor unit and motor impairment in SCN8A DEE. Thus, we propose to use this
unique mouse model to address the gap in our understanding of the pathophysiology underlying motor
impairment in SCN8A DEE. We will use the T767I mouse to 1) determine how Scn8a-T767I affects motor unit
structure, function and connectivity, 2) determine how expression of Scn8a-T767I in motor neurons affects
neuromotor development, and 3) determine whether motor impairment can be prevented or reversed with
administration of an anti-sense oligonucleotide that reduces expression of Scn8a in brain and spinal cord.
Information gained from these studies will provide mechanistic insight into the pathophysiology of SCN8A DEE
that will aid in the development of new therapeutic strategies for this severe disorder.

Public health relevance
PROJECT NARRATIVE Genetic mutations in the sodium channel gene SCN8A cause a severe, early-onset seizure disorder along with significant motor impairment. We have generated a unique new mouse model that is the first to exhibit the motor impairment characteristic of SCN8A epilepsy. This proposal seeks to investigate the pathophysiologic mechanisms underlying motor dysfunction to provide new information that will help guide development of treatments for this debilitating disorder.